COVID - Spplement VACCINE ADJ DISCOVERY PROGRAM (VADP)

To identify the optimal adjuvant for recombinant SARS-CoV2 vaccines, and to identify correlates of protection against SARS-CoV2 infection or disease, experimental SARS-CoV2 vaccines will be formulated with a panel of different vaccine adjuvants and tested side-by-side for immunogenicity and efficacy.